MetaboCore: Needle biopsy assay of drug sensitivity for solid tumors.

Abstract
The goal of personalized oncology is to select the most appropriate drug(s) for individual cancers.
A number of platforms (e.g., organoids and PDX mice) have been developed to generate human
cancer models for drug sensitivity testing, but they have yet to deliver on their promise as an
every-day clinical assay for use by oncologists. The major hurdles limiting success of
personalized drug sensitivity testing are the long turnaround time and the amount of starting
material needed, in addition to the loss of the original tumor microenvironment. To address these
shortcomings, we developed an elegant assay to evaluate drug sensitivity based on metabolic
changes in fresh tumor tissues obtained through needle biopsies. Our so-called MetaboCore
assay takes advantage of an optimized organotypic culture platform that is suitable drug testing
immediately upon specimen collection, and a novel single-cell metabolic assay that detects
changes in metabolism of cancer cells within a short time of drug exposure. Consequently,
quantitative results of relative drug sensitivity can be obtained within a week of the biopsy.
In order to advance our assay towards clinical use, we need to create a robust SOP with
defined parameters for each step of the assay in order to achieve reproducible results. The
objectives of the proposal are to examine how biospecimen preanalytical conditions affect assay
performance. Specifically, we will quantify the effects of each of the following variables on tissue
viability and drug response: type and size of biopsy needles, transport solution, overnight storage,
culture conditions, recovery time, drug concentration, treatment duration, and protocols for tissue
dissociation. Based on these findings, we will create a SOP for MetaboCore and test its clinical
performance in a pilot study using needle biopsies of human liver cancers.

Public health relevance
Project Narrative We have created a novel platform to test drug sensitivity of human cancers using fresh core needle biopsies. It takes into consideration of the tumor microenvironment and provides early readouts of response. Before taking this assay into the clinic, we aim to define the optimal pre- analytical conditions that will allow for reproducible and reliable test performance, including the impact of the type and size of the biopsy needles, tissue handling and storage, culture conditions and dissociation protocols. We will further test our standard operating procedure (SOP) in a pilot study of liver cancers to demonstrate clinical feasibility in preparation for a clinical trial.